Bioconjugations Employing Unnatural Amino Acids

Project Abstract
The ability to prepare well-defined protein/small-molecule/solid-support bioconjugates possesses
significant advantages in the treatment and diagnosis of a variety of diseases. Moreover, the
generation of multivalent conjugates can even further increase the utility and application of these
therapeutics by bringing together multiple partners in a single molecule. However, several issues
associated with their preparation preclude widespread application of these biomacromolecules.
This proposal aims to address these issues via the use of noncanonical amino acid (ncAA)
technologies to rapidly synthesize highly active and well-defined conjugates. Specifically, a variety
of noncanonical amino acids will be synthetically prepared and genetically encoded into proteins
to serve as functionalization handles. First, novel bioconjugation reactions will be developed and
optimized under physiological conditions, including the Glaser Hay coupling between terminal
alkynes and additional reactions based on the diyne moiety afforded by the Glaser Hay. Finally,
the optimized reaction cascades can be combined to produce multivalent bioconjugates that
provide numerous therapeutic properties inaccessible to standard bivalent conjugates. This
includes the linking of an antibody targeting agent to a small molecule drug and a fluorophore to
be able to track drug delivery; however, there are numerous other applications of multivalent
conjugates that can also be envisioned. Ultimately, the methodologies will be transitioned to
biologically relevant systems including ubiquitin binding proteins, esterases, antibodies, MEMO
and Cas9/dCas9. The tools developed within the proposed research will not only significantly
advance the fields of therapeutics and diagnostics, but also be extremely useful in the training of
undergraduate researchers towards their future careers within the scientific arena.

Public health relevance
Project Narrative Bioconjugates provide a mechanism for the targeted diagnosis and treatment of cancer and other diseases. As such, improved methodologies for their preparation can further facilitate their therapeutic and diagnostic value. We aim to both develop novel multivalent bioconjugations, and to synthesize and incorporate unique noncanonical amino acids into proteins in order to address current deficiencies associated with bioconjugate preparation.